ANGIOTENSIN CONVERTING ENZYME INHIBITION IN DIABETIC CHRONIC RENAL NEPHROPATHY

The purpose of this study is to determine if either of two levels of blood pressure control are preferable in patients with established Type I diabetic nephropathy with respect to the rate of decline of renal function, the rate of end-stage renal failure, morbidity, mortality, and the clinical course of proteinuria.